Science and Technology Partnerships

Development of Novel Affinity Reagents: During the past fiscal year, the Office of Science and Technology Partnerships (OSTP) has continued to support an initiative for generating high affinity reagents to serve as tools for molecular interrogation of pathways that become altered during cancer development. Partnerships with three biotechnology companies, Beckton Dickinson Pharmingen, Rockland Immunochemicals, and Epitomics, have led to the creation of nearly 200 novel affinity reagents (polyclonal and monoclonal antibodies) against hundreds of key cancer-related targets of interest to the CCR at minimal cost to CCR investigators. These partnerships represent savings of more than one million dollars to CCR and the NCI. The antibodies that have been developed through these partnerships include:1) novel candidate proteins for which no commercially available antibodies exist; 2) known proteins for which commercially available antibodies exist but fail to meet investigators' requirements; and3) proteins with phosphorylation sites that may be of importance in pathways that are altered during cancer development. All of the antibody characterization data generated by participating CCR investigators is made available to the companies involved through a Web site developed in a collaboration between the OSTP and the Advanced Biomedical Computing Center (ABCC). Each company uses this data in their marketing material when the antibodies are released for commercialization. Our partnership with Epitomics is for production of rabbit monoclonal antibodies. These antibodies are known to be much more stable and have higher affinities than mouse monoclonal or rabbit polyclonal antibodies. The OSTP negotiated a contract with the company to access their antibody production pipeline at a significantly reduced cost ($5,500 versus $20,000 from the catalog price). Similar to the other collaborative programs, CCR investigators will be required to characterize the antibodies and make data available to Epitomics for validation and commercialization.Discovery of Novel Protein-Protein Interactions: The OSTP supported a number of programs for defining novel cancer relevant protein-protein interactions and cell signaling networks. For example, OSTP managed a major screening program to identify and characterize novel binding partners to a large number of cancer-related proteins currently under investigation within the CCR. A CCR-wide partnership with Myriad Genetics was developed to access their automated process for the large-scale identification of protein-protein interactions that is based on the yeast two-hybrid (Y2H) methodology. This large-scale effort between CCR and Myriad generated a host of data (over 1,800 novel protein interactions have been transferred to CCR investigators) that are permitting the delineation of previously uncharacterized signaling pathways and a better understanding of the molecular basis underlying cancer. The data derived from these screens has been made available to CCR investigators through a Web site developed in collaboration between OSTP and the ABCC. The OSTP is now supporting a number of protein interaction screens in mammalian cells for CCR investigators through the Laboratory of Proteomics and Analytic Technologies.Facilitating Access to Genomic Technologies: The OSTP has been evaluating all commercially available platforms for microarray and other high throughput genomic technologies. To make the latest advances easily accessible to CCR researchers, the OSTP has established a number of contracts and pricing arrangements with companies providing genomic profiling technologies and services (Affymetrix, NanoString, Agilent, Illumina, GenUs, Qiagen, etc). These agreements have led to far lower cost and an efficient and easy way for CCR investigators to access these technologies. A subsidy program has been established providing subsidies to the CCR community for all microarrays that are purchased from these companies or full-service microarray analysis that is requested. This funding mechanism has helped to extend the limited research dollars available to CCR laboratories and has permitted our researchers to conduct experiments that might otherwise be cost prohibitive. Many of the funded projects have led to important publications in top tier journals. Most recently, the OSTP has been coordinating CCR's efforts to access the ultra high-throughput, next-generation sequencing technologies. The OSTP has worked with SAIC-Frederick, Inc., to create a new sequencing facility located at the NCI's Advanced Technology Center (ATC) in Gaithersburg, MD. This facility, began operation three years and is now making next-generation sequencing technology broadly available to all NCI researchers. We have also installing a new Illumina MiSeq system in building 37 for access to any CCR investigator.Tools for Bioinformatics and Biostatistics Analysis: In response to CCR's rapidly growing need to manage and analyze large sets of genomic and proteomic data, the OSTP has developed several partnerships with bioinformatics companies. At significant cost savings to NCI, OSTP negotiated a variety of license agreements on behalf of all NCI researchers for universal access to sophisticated tools for bioinformatic and statistical analysis of microarray experiments, arrayCGH studies, proteomic profiling studies, and genomic analysis, including next generation sequencing data. In addition, the OSTP has made a number of software applications for the investigation of pathways and biological association networks available to all of NCI.The OSTP continues to assess CCR's requirements in the area of bioinformatics and biostatistics. We continue to work with the SAIC Information Systems Program to create a CCR-dedicated Bioinformatics Program to provide support to CCR investigators. Hiring of personnel is ongoing and should be completed by the end of this calendar year. Support for analysis of high throughput genomic and proteomic data is being made available through this new core, which is located on the Bethesda campus.